Health People 2020 Initiative: Heart Disease and Stroke survey

Agreement with NCHS to support the National Health Interview Survey (NHIS) measures that assess progress toward achieving Health People 2020 Heart Disease and Stroke Objectives.